Instantaneous Tumor Spray for Real-Time Surgical Guidance

Early stage ovarian cancer is typically asymptomatic. Undiagnosed until the disease has reached an
advanced stage, the disease presents extensive intra-abdominal peritoneal metastases.
Standard of care treatment includes either a surgical cytoreduction to remove tumor bulk, then platinum-based
chemotherapy or primary neoadjuvant chemotherapy followed by interval cytoreduction after tumor shrinkage.
Despite successful initial treatments, 80–90% of women with advanced cancer experience tumor recurrence.
Surgical outcomes can vary considerably since some cancerous lesions are not visible to naked-eye
surveillance or palpation, the only tools available to the surgeon in real-time. There is significant evidence that
an extended disease-free period or even a cure are causally related to how much cancerous tissue is excised.
A sensitive, specific, easy to visualize dye which precisely highlights small (< 5mm) and otherwise hidden
lesions would better differentiate healthy from cancerous tissue, enable better informed surgical decisions and
lead to better outcomes for ovarian cancer patients.
In this collaboration between Molecular Targeting Technologies, Inc. and Weill Cornell Medical School we are
developing a novel, tumor-specific agent for intraoperative near-infrared fluorescence imaging to guide ovarian
cancer surgeries in real-time. In preliminary feasibility studies we have identified an optimized pH-sensitive
near-infrared fluorogenic dye (CypH-11) which is non-fluorescent in normal tissues, but fluoresces immediately
when sprayed onto cancer tissue, whose microenvironment is slightly acidic. We hypothesize that the cancer
selective staining by CypH-11 will make the surgical debulking procedure precise and effective by locating
normally unseen small and occult lesions, achieving a better surgical outcome. This approach could herald a
paradigm shift in surgical oncology.
In direct to Phase II SBIR studies we will scale-up synthesis and manufacture of CypH-11 and the final
formulated vial in compliance with cGMP; perform preclinical optimization and validation of the CypH-11
formulation in a subcutaneous murine model and validate its sensitivity and specificity in an orthotopic model
that simulates the clinical setting; and obtain pharmacokinetic, biodistribution and toxicity data to support an
exploratory IND filing. The application will be submitted to the FDA anticipating a Phase 0 first-in-human study.

Public health relevance
There is no reliable way for surgeons to see all cancerous tissue, including small lesions, in real-time, while operating. We are developing a sprayable, fast-acting, sensitive and tumor specific fluorescent agent which makes ovarian cancer tumors glow under near infrared light during surgery. Our technology can potentially make the ovarian cancer debulking procedure more precise and safer, enabling the surgeon to see more cancerous tissue, improving surgical outcomes and reducing the odds of recurrence.